Bioengineered, patient-specific bonemarrow model for studying leukemic niche interactions

PROJECT SUMMARY / ABSTRACT
Acute leukemias represent the most frequent group of cancer (~30%) in children and young adults. The
advancement of experimental therapeutics for high risk leukemias has been limited by the inadequacy of
immortalized cell lines and the cumbersome nature and limited throughput of in vivo xenograft models. In this
context, the lack of robust systems for in vitro culture of primary leukemia samples is a significant barrier for the
development of effective genetic and chemical screens in pediatric leukemia. In vitro systems, including
engineered tissues and organ-on-a-chip systems, are gaining increased interest in the stem cell and cancer
fields as human-specific platforms for the study of disease and therapeutic testing. In vitro models of the bone
marrow (BM) have yet to gain momentum, largely due to their reduced throughput, technical barriers in biological
research, and the heterogeneity of starting stromal cell populations. Further, there have been only few attempts
to culture primary donor-derived malignant blood cells in engineered systems, which enable patient-specific
studies of disease. In this proposed project, I will (Aim 1) engineer a human, induced pluripotent stem cell (iPSC)-
derived bone marrow tissue model, comprised of osteoblasts, mesenchymal stromal cells, and endothelial cells
within a bone scaffold, for maintenance of acute lymphoblastic leukemia (ALL) phenotype in vitro. I will then use
this model to (Aim 2) study how the secretome of malignant ALL blasts, or the ALL blasts themselves, interact
with both healthy hematopoietic stem and progenitor cells (HSPCs) and healthy stroma in the engineered model.
I hypothesize that an engineered human BM microenvironment, capable of supporting HSPCs in vitro, will
maintain the phenotype of ALL blasts closer to unmanipulated samples than monolayer cultures or patient
derived xenograft models, further enabling studies of direct and indirect lymphoblast interactions with the healthy
bone marrow. It has been well established that acute leukemias alter their microenvironmental niche, and in
many cases, use the stroma to protect malignant clones during treatment; I hypothesize that this model system
will be better able to predict therapeutic responses, identifying potential mechanisms of resistance in ALL. Our
lab brings strong expertise in engineering human tissues, iPSC technologies, and therapeutic testing, and with
support of experts in hematopoiesis, cancer, and sequencing, I believe that the proposed project will successfully
establish a novel tool for studying the human bone marrow during malignant leukemic transformation and
resistance to therapy.

Public health relevance
PROJECT NARRATIVE Acute leukemias represent the most frequent group of cancer (~30%) in children and young adults. Despite much effort in therapeutic development, these advances are hampered by the low predictive value of therapeutics tested in immortalized cell lines as a result of genetic, epigenetic and metabolic reprogramming, as well as the major limitations of xenografts including low engraftment efficiencies and differences among species. This proposal seeks to overcome current barriers in leukemia experimental therapeutics research by developing a novel human, patient-specific bone marrow model for characterization of malignant stromal-hematopoietic interactions and efficacy of therapeutics in high risk lymphoblastic leukemias.